Development of a Medication Adherence and Monitoring System Supporting Decentralized Clinical Trials for Substance Use Disorder

SUMMARY
The primary goal of this project is to adapt Addinex’s existing medication management system to provide
researchers running clinical trials for substance use disorder (SUD) to now have a tool that will allow at-home
dispensing that controls access, monitors usage, educates patients, and collects real-time feedback.
The Addinex system involves packaging medication in low-cost mechanical dispensers where each medication
dose requires a unique password provided by a smartphone app. The dispenser restricts medication access by
limiting each individual dose only as prescribed through unique one-time passcodes. Before each passcode is
released, the patient is provided with education or questions provided by the clinician to monitor their progress.
Proper passcode entry via dial-turning and the pull of a lever dispenses the next dose to the patient. To add a
added level of control, patients may be required to use the app to video themselves taking the medication to
assure compliance. Future dose codes are not released until the prescribed interval has passed, at which point
they can request the next passcode.
To refine Addinex’s system for decentralized clinical trials (DCTs), Addinex is partnering with the Chair of
Psychiatry and Behavioral Health at Greenwich Hospital experienced in addiction medication research, Total
Care Rx who fills prescriptions for Addinex’s current phase II study with Columbia University Medical Center,
Myonex, a leading clinical trial supply company, and an addiction researcher at Yale School of Medicine who
has previously worked with Addinex. These four partners will assist Addinex in developing a seamless version
of its app and clinician data portal to improve at-home patient monitoring and
Addinex intends to (Aim 1) determine weaknesses in current SUD treatment patient onboarding, adherence, and
data collection, (Aim 2) expand the existing Addinex medication dispensing and monitoring system for DCT of
SUD patients to improve patient retention and medication adherence, and (Aim 3) evaluate the usability and
acceptability of the Addinex DCT system for SUD clinical trials. The project’s main goal is to develop a system
to improve recruitment and retention of patients in clinical trials for SUDs.

Public health relevance
NARRATIVE Clinical studies for substance use disorders have unique requirements that limit recruiting, retention, and diversity that can be overcome with tools that allow at-home medication education, control, and monitoring. Based on successful results in a study with post-surgical cancer patients using the Addinex system for opioids and adapting the system for Suboxone from a CDC grant, Addinex now proposes to further refine our system for decentralized clinical trials by partnering with a leading hospital, pharmacy, and clinical study supply company to develop a comprehensive at-home medication monitoring system that can improve recruitment, retention, and monitoring while limiting medication diversion.